Extremely high-throughput mapping of protein, RNA, and chromatin interactions in health and disease

Extremely high-throughput mapping of protein, RNA, and chromatin interactions in health and disease
Abstract
This Catalyst project aims to removing a major bottleneck in understanding diabetes and its complications, by
developing the technologies to map diverse molecular interactions in the disease-relevant cells at the genomic
scale. These proposed technologies, collectively called PRACI (Protein, RNA, and chromatin interactions), will
enable a typical research lab to map genome-wide protein-protein, RNA-protein, RNA-RNA, and RNA-
DNA/chromatin interaction networks from a given cell type within 1 months’ time. PRACI enables typical labs to
compare molecular interaction networks between health and disease states. Without PRACI, genome-wide
mapping of even a single type of interactions from a disease-relevant cell type remains a formidable task.
I will systematically map molecular interactome changes related to diabetes related vascular complications, using
hyperglycemia and chronic inflammation-induced irreversible alterations vascular endothelial cells as a testbed
system. I anticipate to reveal which components of the multiscale molecular networks are responsible for the
sustained dysregulation of gene expression in dysfunctional endothelial cells. Such information will lead to new
perspectives to diabetic wound healing, given the established roles of endothelial dysfunction to diabetic wounds
and the relative accessibility of vasculature. I anticipate that these technologies and their enabled discoveries
will contribute to and inspire transformative changes in the study of Diabetes, Endocrinology, and Metabolic
Diseases.

Public health relevance
Extremely high-throughput mapping of protein, RNA, and chromatin interactions in health and disease Project narrative This project will develop extremely high-throughput technologies and companion bioinformatics tools for mapping diverse types of molecular interactions at the genomic scale. I will identify protein-protein, RNA-protein and RNA- chromatin changes at whole-genome scale in diabetes related vascular complications, specifically in hyperglycemia and chronic inflammation-induced irreversible alterations vascular endothelial cells. I anticipate that these technologies and their enabled discoveries will contribute to and inspire transformative changes in the study of Diabetes, Endocrinology, and Metabolic Diseases.